Puerto Rico Minority Underserved NCI Community Oncology Research Program (Puerto Rico MUNCORP)

PROJECT SUMMARY/ABSTRACT
The PR NCORP will be the only organization that conducts significant, meaningful NCI - directed
Clinical Cancer Research on the island of Puerto Rico focused on minorities and underserved
communities for cancer treatment and cancer care delivery. It will be the backbone for the
development of the multidisciplinary cancer care for the newly built University of Puerto Rico
Comprehensive Cancer Center (UPRCCC), which will officially open to patient care on August
20, 2018. All faculty members including translational researchers and clinical care providers are
expected to participate in the PR NCORP for the purposes of broadening the catchment base for
accrual to our clinical trials. Each department within the CCCUPR, such as Gynecologic
Oncology for example with four active faculty surgeons, will participate directly in NRG studies
and will use the PR NCORP as the platform for development of the department. All patients seen
in the CCCUPR will be consented for enrollment in the PR NCORP broadly for purposes of
demographical and clinical data gathering with specialized consent for tissue donation.
The PRNCORP is also a source of knowledge to the broad oncology medical community. It will
serve to improve cancer treatment and care for Adult and Pediatric patients throughout its
participating institutions and beyond. Our PI's and Co-PI's are experienced professionals with
over 30 years of experience in Clinical Research with very strong staff and support personnel.
Our fellows and attendings are active participants of Medical Schools, tumor boards, cancer
seminars and are involved in yearly updates to the Medical Community, such as ASCO and ASH
Review Conference Series in the island. Our research environment will improve: (1) Pathology
Departments, (2) Radiology Imaging Departments, (3) Radiotherapy Service, (4)
Gastroenterology, (5) Surgery, (6) Hematology-Oncology Treatment Program and (7) Direct
Patient Care.

Public health relevance
PROJECT NARRATIVE The PRNCORP represents a coordinated effort of several institutions, medical practices, investigators and research personnel to form a single community-based research program that conducts NCI sponsored clinical research involving a large hispanic population. The program will focus on socioeconomically-disadvantaged individuals and help identity challenges and barriers that impact cancer care and outcomes.